Direct 3D Reconstruction Methods for Electrical Impedance Tomography for Stroke Imaging

Project Summary Every four minutes an American dies from stroke, equating to approximately 1 in every 19 US deaths annually. Strokes are classiﬁed as ischemic and hemorrhagic. Ischemic strokes make up 87% of all strokes and are caused by a blockage in a blood vessel (or artery) resulting in a lack of blood to the brain. A hemorrhagic stroke occurs when an artery in the brain leaks or ruptures releasing excess blood in or around the brain. Incorrect classiﬁcation can have dire consequences as treating a patient suffering from a hemorrhagic stroke (bleed) with anticoagulant drugs (used to dissolve blood clots for ischemic strokes) can prove fatal. Early action is of the utmost importance as each passing minute that brain cells lack the proper blood ﬂow additional cells die. Current classiﬁcation methods require tests performed at the hospital, e.g., CT or MRI scans of the patient's brain, leading to treatment delays. These delays are particularly lengthy for patients living in rural communities. Electrical Impedance Tomography (EIT) is an emerging medical imaging modality that is inexpensive, has no ionizing radiation, and provides portable high-contrast images using harmless surface current and voltage measurements (e.g., on the head using a ﬂexible hat) to recover the internal point-wise electrical properties (e.g., inside the brain). EIT can recover conductivity, a measure of how easily current ﬂows through a material, as well as permittivity, a measure of the ability of a material to store a charge. A hemorrhagic stroke corresponds to an area of abnormally high conductivity due to the bleed, whereas an ischemic stroke presents as an area of lower conductivity than expected due cellular swelling from energy failure. The proposed project addresses the important problem of early, fast, portable stroke classiﬁcation with EIT. A critical barrier for the use of EIT for stroke imaging has been the sensitivity of the image reconstruction algorithms to incorrect domain modeling and noise in the data. Due to these challenges, most research has focused on monitoring applications, not helpful for the classiﬁcation task. By contrast, the D-bar reconstruction method proposed here is the only proven noise and modeling error robust reconstruction method capable of recovering the true conductivity/permittivity using a low-pass ﬁltering in a nonlinear Fourier domain. D-bar methods have been successful in 2D but their development in 3D is stunted. This proposal focuses on the development of fast, robust D-bar based reconstruction methods for the 3D partial boundary problem, critical to working with stroke EIT data. Numerical algorithms will be developed for the full and partial boundary problems in 3D and validated on simulated and experimental data. A priori information, from anatomical atlases, will be embedded into the methods for increased resolution and stability. As the low-pass ﬁltering in D-bar methods leads to blurred reconstructions, post-processing through Convolutional Neural Networks will provide improved image quality. This work will be the ﬁrst to develop robust computational algorithms for 3D EIT data, opening the door for stroke imaging.

Public health relevance
Project Narrative Electrical Impedance Tomography (EIT), a portable imaging modality may provide early classiﬁcation of stroke type reducing treatment delays thus leading to improved patient outcomes. Existing image reconstruction algorithms for EIT are not robust to practical partial boundary data inherent to stroke imaging. Robust D-bar methods, aided with a priori information from anatomical atlases, will be developed in 3D to address the stroke classiﬁcation and monitoring tasks from practical EIT data.